Decoding the Spatial Grammar of Developmental Signaling

Project Summary
Embryos communicate instructions to their cells using an elaborate language of chemical signals. A defining
feature of this language is its use in space; instructions are encoded in spatially-resolved ‘patterns’ of signaling
molecules. Learning to translate this language of patterns—to read and write instructions that stem cells
understand— is a defining aim of modern developmental biology. This ability would have transformative
implications for regenerative medicine by making it possible to guide the development of replacement tissues in
the laboratory. However, two key challenges must be overcome to realize this goal. First, we need new methods
to create and test developmental signaling patterns. Second, we need modeling frameworks that can predict the
developmental outcomes encoded by arbitrary patterns of signaling. Here, we propose a new approach that
addresses both of these challenges using high-throughput optogenetic manipulation of developmental
signaling. Our strategy combines new reagents for optogenetic control of developmental signaling in human
stem cells with a platform for spatially-resolved light stimulation. Our patterning platform will allow us to create
patterns signaling with single-cell resolution for over 5 million cells in a single experiment. We will leverage the
unique scale afforded by this approach to build deeply-sampled paired libraries of developmental signaling
patterns and resulting tissue structures. This dataset will create exciting new opportunities for modeling
developmental signaling and rationally guiding tissue development in vitro. In this proposal, we lay out a first
application of this approach to the Nodal signaling pathway, which orchestrates endoderm and mesoderm
formation in early vertebrate embryos. First, we will import computational methods from deep learning to build
models that predict the tissue structures resulting from arbitrary Nodal signaling patterns. Second, we will use
these models to guide the rational design of three-dimensional tissues that can be used to grow endodermal
organoids in vitro. Finally, we will use high-throughput optogenetic manipulation to rigorously construct and
constrain mechanistic models of Nodal patterning. To our knowledge, this work will constitute the first high-
throughput screen on spatially-resolved signaling patterns. By empirically sampling pattern space with
unprecedented depth, we aim to establish a new path to the rational engineering of complex tissues.

Public health relevance
Project Narrative A defining goal of regenerative medicine is to build individualized tissues from patient-derived stem cells, However, current approaches do not offer flexible and precise control over stem cell differentiation in space, limiting our ability to rationally design tissue structures. Here, we propose a new method that will overcome this limitation by using spatially-resolved optogenetic stimulation to communicate precise instructions to developing stem cells.